TECHNICAL AND ANALYTIC SUPPORT ON THE NATIONAL SURVEY OF EARLY CARE AND EDUCATION (NSECE) DATASETS

This contract will enhance the analytic capacity of the National Survey of Early Care and Education Data by constructing analytic variables to answer key early care and education questions; processing and disseminating restricted use data that allow for sophisticated analyses of early care and education supply and demand by linking household and program data at the community level; developing technical assistance resources and conducting technical assistance for researchers and analysts wishing to mine the NSECE data; and conducting analyses in response to questions posed by ACF and its early childhood programs.